CRF-Oxytocin Interaction in the Regulation of Stress and Affect

7. Project Summary/Abstract According to the World Health Organization depression affects 121 million people worldwide. Chronic stress and thus increased corticotrophin releasing factor (CRF) signaling is indicated as a potential risk factor for depression. Conversely, depression is linked to decreased function of the central oxytocin (OT) system, which has been also shown to attenuate stress response. Therefore this proposal is designed to explore a complex interaction between the CRF and OT systems in two key brain regions involved in the response to stress and affective behavior. We have recently shown that an intimate neuroanatomical circuit exists between neurons expressing these neurotransmitters in the paraventricular nucleus of the hypothalamus (PVN), a central hub of the stress axis, and in the bed nucleus of the stria terminalis (BNST), a brain region responsible for the affective component of the stress response. Hence, OT neurons in the PVN selectively express CRF type 2 receptors (CRFR2) and send oxytocinergic input to the BNST, where OT axons and terminals also express CRFR2. Notably, these OT-positive axons make perisomatic contacts with CRF neurons of the BNST, which in turn express high levels of the OT receptor (OTR) (Dabrowska et al., 2011). Here we propose a novel concept of a feedback loop between the CRF and OT systems, which could modulate the stress response and affective behavior. In this model, local CRF release following stress would activate CRFR2 on OT neurons in the PVN to induce somatodendritic OT release in the PVN and terminal OT release in the BNST, which would consequently influence emotional behavior. Therefore, the reciprocal interaction between the CRF and OT systems might play a critical role in regulating affective behavior, and I hypothesize that CRFR2 is a key component of this relationship. Thus with this proposal I will determine the role of CRFR2 in the CRF-OT relationship using integrative neuroanatomical, neurophysiological, in vivo microdialysis, and behavioral approaches. I will answer the following critical questions: Specific Aim 1) what is the origin of CRF terminals, which make synaptic contacts with magnocellular OT neurons in the PVN, SA2) whether and how excitability of these OT neurons in the PVN can be modulated by activation of CRFR2, SA3) whether and how activation of CRFR2 impacts OT release in the BNST and PVN, and SA4) whether and how activation of CRFR2 and OTR in the BNST impact affective behavior in control and chronically stressed rats? Four analytical approaches will be used to directly address these questions: SA1) adenoviral-based neuronal tracing studies combined with confocal microscopy, SA2) in vitro whole-cell patch-clamp electrophysiological recordings from OT neurons in the PVN, SA3) in vivo microdialysis of the OT in the BNST and PVN, and SA4) behavioral experiments to define the role of CRFR2 in the CRF-OT interaction in regulating affective behavior following chronic stress. Understanding the nature of the feedback loop between the PVN and the BNST at the functional level would represent a milestone in our understanding of the etiology of the stress-induced affective disorders and could ultimately provide novel directions for the treatment strategies. I am pursuing a career path to become an NIH-funded independent investigator and I already possess the motivation and expertise to independently carry out specific aims 1 and 4. However, to successfully carry out work proposed in specific aims 2 and 3 I will require additional mentoring. I have prepared a detailed mentoring plan and will receive specific training from world-renowned scientists during the mentored (K99) phase of the award. My primary mentor, Dr. Donald Rainnie and my co-mentor, Dr. Larry Young, are both senior, NIH- funded faculty members in the Department of Psychiatry and Behavioral Sciences at Emory University. Their labs are located at the Yerkes National Primate Research Center. Dr. Rainnie is an acknowledged expert in in vitro patch-clamp recording techniques, who has over 20 years experience in electrophysiological recordings from neurons of the extended amygdala. Dr. Rainnie has published key papers on the regulation of these neurons by neurotransmitters such as CRF, and he will personally train me in the whole cell patch-clamp technique as well as teach me the foundations of neurophysiology. Dr. Young, a world-renowned expert in the neurobiology of oxytocin and social behavior, will provide training in the pharmacology of oxytocin and the oxytocin receptor, and he will guide me in the research pertaining to the oxytocin side of the project. Furthermore, Dr. Young will facilitate my training in in vivo microdialysis for oxytocin with his current collaborators from Germany. Dr. Rainer Landgraf from Max Planck Institute of Psychiatry will train me in the radioimmunoassay technique developed in his laboratory, which has the necessary sensitivity that is needed to measure extracellular oxytocin levels in the PVN and BNST. Dr. Oliver Bosch from the University of Regensburg will train me in the construction of custom-made microdialysis probes with the pore size suitable for neuropeptides, as well as probes validation and optimal implantation into the PVN and BNST. My mentoring team will work in a collaborative and organized manner to foster my transition to an independent research career towards the end of the mentored phase of the award. This K99/R00 Career Development Award will enable me to pursue specialized, multi-disciplinary training in the research on the neuropeptide modulation of the affective behavior with great promise for translating my discoveries into novel and better treatments for psychiatric disorders. The mentored phase will accelerate my development towards becoming an independent investigator in an academic setting. In the end of mentored (K99) phase of the award, I will be a highly competitive applicant for academic junior faculty positions. My career objective is to conduct independent research to understand how stress and affect interact and elucidate their respective roles in the etiology of mental disorders like depression and anxiety.

Public health relevance
8. Project Narrative Corticotrophin releasing factor and oxytocin are two powerful neuropeptides that regulate the stress response and emotional behavior. We have shown that these two neurotransmitters are linked in a reciprocal anatomical circuit. In this proposal we will use a multidisciplinary approach to elucidate how they functionally interact with each other, and what role this interaction plays in the etiology of mental disorders like depression and anxiety. Understanding the functional interaction between these two neuropeptide systems could ultimately provide novel directions for the development of pharmacotherapy for stress-related affective disorders.